Neuropeptide receptors, behavioral states and acute ethanol effects

PROJECT SUMMARY
There are two, partially overlapping goals of this research: (1) comprehensively define the array of G protein-
coupled neuropeptide receptors that act to modulate and mediate acute actions of ethanol in vivo. (2)
investigate the impact of specific behavioral states on acute sensitivity to ethanol. We will characterize the
roles of all neuropeptide receptors in C. elegans in basal locomotion behaviors and ethanol-induced behavioral
effects. This comprehensive assessment will identify receptors that positively and negatively regulate the
neuronal circuit that controls locomotion and those receptors that act to promote or negatively regulate ethanol
actions. We will assess both the level of initial sensitivity to ethanol and the time-dependent development of
acute functional tolerance to the drug. In addition, for those receptors that act to modify responses to ethanol,
we will classify any interactions with the neuropeptidase nep-2, which is orthologous to the mammalian
neprilysin protein. The mammalian neprilysin protein is involved in the regulation of levels of multiple important
signaling peptides, including enkephalins, tachykinin, substance P and others. A mutation in the nep-2 gene
produces an ethanol-resistant behavioral phenotype. We hypothesize that a peptide target of NEP-2, which is
likely to be elevated in a nep-2 mutant background, acts to counteract acute effects of ethanol via increased
signaling through a neuropeptide receptor. The proposed experiments will identify that receptor and test the
hypothesis that the receptor acts in a defined neuronal circuit that controls behavioral state decisions. Our
preliminary data has identified several mutants that affect both ethanol responses and a behavioral state
decision that affects exploratory behavior. The circuit that regulates that decision is well defined, and includes
the sites of action of neuropeptides and serotonin. We will define networks of genes that act to regulate that
behavioral decision and ethanol responses, and test specific neurons in the controlling circuit for their role in
regulating ethanol responses. The relationship between an emotional (or affective) state in humans and the
problematic use of drugs of abuse is of significant interest. The successful outcome of this proposed research
will provide a better understanding of how specific behavioral states, controlled by a known regulatory circuit,
can impact the acute responses to an abused drug. There is a significant correlation between the level of an
individual’s initial response to alcohol and their likelihood to develop an alcohol use disorder (AUD). Genetic
variation in any of the human orthologs of the C. elegans genes identified in this study has the potential to alter
an individual’s level of response to ethanol, and therefore could impact that individual’s predisposition to
develop an AUD later in life.

Public health relevance
PROJECT NARRATIVE This proposal uses alcohol to change nervous system function and test which neuropeptide receptors can act to oppose or promote the action of alcohol. The biological relationship between a behavioral state, a neuronal circuit and the identified neuropeptide receptors will be examined to understand the mechanisms of action.